Mechanistic insights into translesion synthesis-dependent genome instability

Genome instability, characterized by increased formation of DNA mutations and other genetic
modifications, is a causative factor in multiple human diseases including cancer, infectious
diseases, and neurodegenerative disorders. The translesion synthesis (TLS) pathway, by means
of its low fidelity polymerases, causes mutagenesis by bypassing DNA damages and filling post-
replicative DNA gaps; a process principally orchestrated by the REV1 polymerase. Thus, TLS
and REV1 are essential components of genome instability that drive the formation of new
mutations that then translate into new, and often deleterious cellular functions. Recent discoveries
from my laboratory challenge this one-dimensional model and have profound implications for
understanding human disease and may offer opportunities to develop new therapeutics. We have
discovered that the REV1 polymerase has a broader role in controlling genome instability than
originally thought. REV1 regulates autophagy, metabolic processes, mitosis fidelity, and
replication stress through rereplication. We have evidence that these additional, previously
unrecognized roles of REV1 regulate cellular metabolic choices of autophagy versus senescence
in response to different types of DNA damages and as such might control cell death mechanisms.
Furthermore, our preliminary data unexpectedly showed that REV1 directly regulates autophagy,
mitosis, and rereplication proteins. While these early results are enticing, the fundamentals of
these discoveries—how REV1 controls cellular metabolism and participates in mitosis fidelity and
rereplication are a black box. The work proposed here will systematically tease apart the
mechanistic basis of the new roles of the REV1 polymerase. The goals of this proposal are to
determine the mechanisms by which REV1 exercises these newly recognized functions by
utilizing novel and cutting-edge tools to ask basic biological questions. Successful completion of
our proposed studies will redefine the role of REV1, from an error-prone polymerase that
participates in the TLS DNA mutagenesis process to a multi-dimensional regulator that controls
disease onset or progression by not only making mutations in DNA, but also by controlling cellular
metabolism, mitotic fidelity, and rereplication, central to the genome instability process.

Public health relevance
Genome instability, which is associated with multiple human diseases, is a byproduct of mutations that accumulate in the human genome as a result of the error prone DNA copying translesion synthesis (TLS) enzymes. Recent publications and strong preliminary work from my lab have shown that the TLS REV1 polymerase regulates metabolic pathways, mitotic fidelity, and replication stress, all of which are known to be associated with genome instability. This proposal will determine the molecular mechanisms by which REV1 controls these non-TLS functions and their potential roles in genome instability.